Functional Alterations of Parvalbumin Interneurons Contributing to Abnormal Network Activity in Alzheimer's Disease Mouse Models

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is the most common form of dementia and the sixth leading cause of death in the
U.S. that affects 5.7 million Americans. There is no cure for AD and it has been 15 years since the latest AD
drug, Memantine, was approved by the FDA. Remarkably, AD patients show fluctuations of cognitive function
in the course of hours or days. This behavior cannot be explained by the sudden loss or gain of neurons,
neurofibrillary tangles or beta-amyloid plaques. Instead, lucid moments experienced by AD patients likely
represent emergence of normal neuronal network activity that is disrupted by pathological events in the AD
brain. In both AD patients and mouse models of AD, neuronal network hypersynchrony (epileptiform
discharges and seizures) and altered oscillatory network activity (brain rhythms) are observed. Recent
discoveries show that inhibitory interneuron dysfunction is a key upstream mechanism leading to network
hypersynchrony, decreased behavior-dependent gamma oscillatory power and impaired cognitive function in
the J20 model of AD. Deficits in inhibitory interneurons are found in both AD patients and mouse models of AD
where levels of the voltage-gated sodium channel subunit Nav1.1 are decreased in the parietal cortex. Nav1.1
is predominantly expressed in the parvalbumin (PV)-positive inhibitory interneurons, which generate gamma
oscillatory activity that increases during sensorimotor and cognitive. PV interneurons are critical in modulating
cognition-associated gamma oscillatory activity, however, the in vivo functional deficits of PV interneurons and
how PV interneurons contribute to disrupted gamma rhythms and network hypersynchrony in AD is unknown.
Using in vivo two-photon imaging, electroencephalogram (EEG) recordings and behavioral assessments, the
relationship between in vivo PV cell activity and altered gamma oscillations in behaving head-fixed J20 mice
will be determined (Aim 1). Furthermore, Long-term EEG recordings will help to dissect the role of PV
interneurons in brain-state- and disease-state-dependent network hypersynchrony (Aim 2). Completion of the
first two aims during the mentored phase of this award will allow the full development of an innovative
technique, which enables a new research direction towards the interaction of inhibitory interneurons with other
cell types in the brain to determine the cause and effect of interneuron dysfunction in AD. During the
independent phase of this award, Aim 3 investigates how in vivo dysfunction of PV interneurons causes
dysregulation of excitatory neuron activity contributing to altered oscillatory activity and network
hypersynchrony in J20 mice. Genetic Nav1.1 overexpression will be used to modulate PV cell function to gain
further mechanistic insight in all three aims. The long-term goal is to understand how inhibitory interneurons
modulate oscillatory rhythms in the brain to alter cognitive function. This mechanistic insight could potentially
lead to improvement of cognitive function in AD patients by manipulating inhibitory interneurons and network
function, similar to AD patients having lucid moments, irrespective of other pathologies in the brain.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease is the most common form of dementia and the sixth leading cause of death in the U.S., but this devastating disease has no cure. Currently, 5.7 million Americans are living with Alzheimer's disease and 1 in 3 seniors die from dementia, which is more than breast cancer and prostate cancer combined. This research will reveal novel insights on the functional abnormalities of neurons that underlie cognitive impairment in Alzheimer's disease.